Investigating B cell central tolerance to a model commensal antigen

Abstract: How the immune system establishes homeostasis with commensals is an area of intense study that
is directly related to human health. B cells must balance the need for a diverse B cell receptor (BCR) repertoire
while maintaining self-tolerance. Tolerance is enforced through multiple checkpoints, including deletion, receptor
editing, and anergy. Importantly, anergized cells may become activated under specific circumstances, suggesting
that these cells may help balance the need for robust pathogen reactivity with self-tolerance. Commensal
microbes provide a complex challenge to this paradigm, as they harbor foreign antigens and yet must be
contained without triggering overwhelming inflammation. Their persistence raises the question of how such
antigens are distinguished from self. If, or how, microbial antigens could induce tolerance in host immunity is
unknown. This proposal will test a new model in which a ubiquitous microbial antigen apparently functions as a
tolerizing self-antigen for developing host B cells. To create the molecular and cellular tools to address these
questions in a mechanistic and cause and effect fashion, we have generated three BCR-knock-in mice
expressing LPS-specific BCR’s of either low- or high-affinity heavy chains (33HGL and 33Hhigh), or a high-affinity
light chain (33Lhigh). These BCRs were derived from an expanded B cell clone that was responding to infection
with Salmonella. B cells carrying these LPS-specific BCRs show clear evidence of clonal deletion and anergy.
Intriguingly, lowering the BCR affinity for LPS reduces the stringency of negative selection. Critically, when bone
marrow from SPF mice was transferred into lethally irradiated germ-free (GF) mice, we observed substantially
reduced clonal deletion at each developmental stage. The marked reduction of self-tolerance in the absence of
microbiota strongly suggests that these BCR knock-in B cells are tolerized to a microbial product, presumably
LPS. Here we propose to formally prove and define the nature of this commensal-driven tolerance. In Aim 1 we
will transfer GF bone marrow chimeras back to SPF conditions to define contexts in which tolerance is perturbed.
In Aim 2 we will isolate specific commensal bacteria that react with the 33HL BCR, further defining tolerance
mechanisms and creating tools for future study. Preliminary experiments also show that tolerized B cells indeed
differentiate to antibody secreting cells in response to Salmonella infection. Thus, in the third Aim, we will define
the nature and longevity of this B cell response, and determine whether they provide protection from challenge
with a pathogenic strain of Salmonella. This will assess the functional consequences of tolerance to commensals
on their capacity to respond to a cross-reactive infection. Developing and understanding this novel system, in
which we track a single pathogen-specific B cell clonotype, to determine how it may be both tolerized by
“commensal self” as well as provide protection during infection will provide new insights into how microbiota
influences the B cell compartment. This in turn has implications for understanding intestinal inflammatory
conditions, dysbiosis, and intestinal barrier breach such as with chemotherapy or infection.

Public health relevance
Project Narrative: Tolerance to commensal microbial antigens is dysregulated in situations of intestinal barrier disruption, such as intestinal inflammation and during cancer treatment. B cells play a crucial role in this process through antigen presenting functions and production of commensal-specific IgA, but if or how B cell tolerance is established prior to reaching intestinal tissues is largely unknown. In this proposal we will use a new mouse strain to study the effects of commensal bacterial antigens on B cell development and tolerance in homeostasis and disease settings.